Volunteering, Polygenic Risk, and Cardiovascular Biomarkers in Multiple Ancestry Groups

ABSTRACT
There is increasing knowledge that volunteering is salutary for volunteers’ cardiovascular health.
At the same time, more than 50% of adults over the age of 50 in the U.S. report at least one
cardiovascular risk such as hypertension, high cholesterol, obesity, and chronic inflammation.
Despite decades of research indicating that frequent volunteers show better cardiovascular
disease (CVD) biomarkers, little is known whether frequent and sustained volunteering affects
change in CVD biomarkers in multiple population subgroups, net of selection into volunteering.
Further, genetic susceptibility to CVD biomarkers has never been studied in the context of
volunteering. Our preliminary data show that frequent volunteering (200+ hours a year) predicts
favorable CVD biomarkers, including chronic inflammation, systolic, and diastolic blood pressure
in longitudinal analysis even when selection effects are considered through inverse probability
treatment weighting. This highlights a critical need for understanding the pathways by which
genetic, social, and behavioral factors affect cardiovascular health in older adults (NIA strategic
research priorities B-2). In response to PA-20-185 and NOT-AG-21-020 Maximizing the
Scientific Value of Secondary Analyses of Existing Datasets, the present study uses the Health
and Retirement Study and seeks to understand whether changes in volunteering are linked to
CVD biomarkers over a decade after adjusting for selection into volunteering and pre-baseline
characteristics, and whether these links are stronger for multiple genetic, demographic, and
socioeconomic subgroups. Using seven CVD biomarkers and polygenic risk scores, this study
addresses three specific aims: Aim 1) examine the longitudinal effects of sustained volunteering
on CVD biomarkers (N=18,847), Aim 2) test the associations between genetic predictors of
CVD biomarkers, volunteering and CVD biomarkers in multiple ancestry groups (European
N=8,400, African N=1,605), and Aim 3) assess the effect heterogeneity of volunteering on CVD
biomarkers in multiple genetic, demographic, and socioeconomic subgroups. This project seeks
to quantify the effects of volunteering on multiple CVD biomarkers while addressing important
questions about selection effects and genetic susceptibility for a better causal inference.
Addressing this gap in research is critical for developing new public health policies and
biobehavioral and social interventions for heart-healthy older adults.

Public health relevance
Narrative This project aims to quantify the effects of sustained volunteering on multiple modifiable cardiovascular disease (CVD) biomarkers while considering the selection into volunteering, genetic susceptibility for clinically high CVD biomarkers, and the effect heterogeneity in multiple population subgroups. Findings from this ten-year longitudinal study of older adults will inform the optimal level of volunteering among older adults, identify which population subgroups should be targeted for volunteering interventions, and show how genetic information informs research on volunteering and health. This study will also provide insight for future research to examine the complex trajectory of volunteering and cardiovascular health in middle-aged and older adults.